The mechanism and regulation of autophagy

Autophagy represents a complex pathway of cellular homeostasis that functions in cytoprotection, but if
dysregulated can cause cell death; a complete knowledge of regulation is critical for the potential modulation
of this process for therapeutic purposes, and to increase our basic understanding of membrane dynamics and
organelle biogenesis. Autophagy occurs in all eukaryotes, and the protein components of the autophagic
machinery are conserved from yeast to mammals. The hallmark of this process is the formation of double-
membrane cytosolic vesicles, autophagosomes, that contain cytoplasmic components sequestered by the
phagophore, a unique transient compartment. After completion, the autophagosomes fuse with the
lysosome/vacuole to release the inner vesicle that is broken down, allowing access to the cargo. Autophagy
plays a role in various developmental processes and is associated with a range of pathophysiological
conditions. The long-term goals of this proposal are to understand the mechanism of action of the autophagy-
related proteins, how the process is regulated, and why specific mutations result in human disease.
In the last 20 years, we have learned much about the molecular aspects of autophagy—43 fungal
autophagy-related (Atg) proteins have been identified, but we only have a cursory knowledge of their function.
In addition, autophagic dysfunction is associated with numerous diseases in humans, including cancer, heart
disease and neurodegeneration. Although autophagy is primarily cytoprotective, excessive autophagy is
detrimental. Thus, we need a full understanding of the regulatory network in order to apply therapeutic
interventions aimed at treating disease through autophagy modulation. In the next five years, we want to (1)
understand the structure and function of the Atg proteins; (2) define the regulatory controls that allow
autophagy induction, determine the switch between specific and non-specific types of autophagy, and
maintain autophagy at appropriate levels; and (3) decipher the relationship between mutations affecting
autophagy and diseases, with an ultimate goal of facilitating treatment. We are using yeast to investigate the
molecular mechanism of autophagy; this is the best system for a molecular genetic and biochemical analysis
of this complex process. Because of the high degree of conservation, however, the information we learn from
yeast will be applicable to more complex eukaryotes.
The experiments described in this proposal are significant because they will elucidate important links
between upstream regulatory components and the machinery that carries out autophagy, providing the next
step in a comprehensive analysis that links the signal transduction elements to the functional apparatus,
advancing our knowledge of basic cell biology, and identifying targets for ultimate therapeutic intervention.
The proposed research is innovative, because it is providing new, and in some cases paradigm-shifting,
information about the regulatory and functional components of autophagy.

Public health relevance
Autophagy plays a role in normal physiological processes including fetal development and innate immunity, and its dysfunction has been implicated in a wide range of human diseases including cancer, some types of neurodegeneration, bacterial and viral infections, gastrointestinal disorders, diabetes and heart disease. It may be possible to modulate autophagy for therapeutic purposes, turning it on and off at precise times, and in specific tissues, to prevent or ameliorate the onset of diseases or their symptoms. To use autophagy in this manner, however, will require a complete understanding of its mechanism and regulation.